Core E: Cellular and Organismic Systems for Antiviral Testing

Core E – Cellular and Organismic Systems for Antiviral Testing
Summary
The Cellular and Organismic Systems Core supports the entire Midwest AViDD Center by coordinating and
implementing cell and animal antiviral testing experiments required to address the aims in each of the Projects.
A Cellular and Organismic Systems Core group is necessary for this AViDD Center because of the need for
consistency in determining the antiviral activity of each compound, and because of the intense requirements for
handling pathogens that require high containment. Based at the University of Minnesota, Boston University and
the University of Iowa, the Cellular and Organismic Systems Core provides the specialized resources and
administrative framework for performing cellular and animal BSL2, BSL3, BSL4 studies. Core E will focus on
SARS-CoV-2, Zika virus, Ebola virus and Lassa virus. This core will evaluate validated hits through high
throughput screening in Aim 1. Successful compounds will then go back to the projects and cores for further
refinement. Aim 2 will then evaluate refined compounds for antiviral activity and dose response, the potential for
escape, and efficacy in primary human cells. Finally, compounds that demonstrate efficacy in Aim 2 will be
evaluated for prophylactic and therapeutic efficacy in relevant animal disease models in Aim 3.

Public health relevance
Core E – Cellular and Organismic Systems for Antiviral Testing Relevance Readily available and efficacious interventions for viruses with pandemic potential are desperately needed. Antiviral testing using live virus in relevant cell and animal models is essential to evaluate drugs these drugs. This Core’s expertise in coronaviruses, flaviviruses, arenaviruses and filoviruses will allow us to provide rigorous antiviral evaluation in coordination with the 5 projects and 5 other cores.